Administrative Core

ADMIN CORE - PROJECT SUMMARY
The Administrative core of the Peds Program will serve as the central entity overseeing research
productivity, compliance, reporting, and synergy between Projects, Cores, and Subaward activities. To do this,
the Aims of the core will include (1) to foster communication and synergy across the Peds Program by
coordinating and streamlining scientific communication and data sharing, (2) to coordinate administrative and
fiscal responsibilities efficiently to maximize scientific advancement toward research aims across all Projects and
Cores, (3) to maintain effective scientific oversight of research progress, quality control, subaward activities, and
Core services. The PI, co-I, and staff of the Admin core, which includes extensive Program Management
experience, will ensure optimal scientific synergies and outcomes of the Peds Program.